Biological Magnetic Resonance Data Bank

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Biological Magnetic Resonance Data Bank (BMRB) is the authoritative worldwide resource that provides free access to the wealth of information on biomolecules derived from nuclear magnetic resonance (NMR) spectroscopy. These NMR experimental data underlie the three-dimensional structures and conformations of many proteins and nucleic acids and provide important insights into their dynamics, chemical properties, and molecular interactions. NMR is also useful for characterizing biomolecular interactions, with applications to drug discovery, and in quantifying the components of complex mixtures of biomolecules, including metabolites and natural products. Data archived at BMRB include chemical shifts, peak intensities, scalar couplings, dipolar couplings, and relaxation and cross-relaxation rates. BMRB integrates these NMR data into a unified, global, molecular database of general utility to the broad scientific community. The growing volume of data available from BMRB is catalyzing transformative scientific applications, such as the determination of protein structure and dynamics directly from chemical shifts. BMRB maintains software tools for integrating the retrieval, analysis, and display of NMR data in the context of molecular structure and conformation. As a member of the World Wide Protein Data Bank (wwPDB), BMRB has close ties with the other wwPDB partners: the Research Collaboratory for Structural Bioinformatics (RCSB), the Protein Data Bank in Europe (PDBe), the Electron Microscopy Data Base (EMDB), and the Protein Data Bank of Japan (PDBj). In its role in the wwPDB, BMRB implements standards for NMR data types and maintains software for data deposition and validation. This project supports ongoing operation of BMRB, including maintenance of deposition pipelines and infrastructure to support search and retrieval of NMR data, and to maintain a productive dialogue with users and creators of biomolecular NMR data to increase the impact of the archive, and to maintain BMRB’s role in the wwPDB.

Public health relevance
PROJECT NARRATIVE The Biological Magnetic Resonance Data Bank (BMRB) data repository supports the biomedical research efforts of the world wide biomolecular magnetic resonance (MR) community. Magnetic resonance spectroscopy is a key tool used to understand the biomedical significance of protein and nucleic acid structures, to identify potential drug therapeutics, and to characterize metabolites and disease biomarkers.